Cancer Center Support Grant

Director's Overview: Project Summary/Abstract
The UCSF Helen Diller Family Comprehensive Cancer Center (HDFCCC) seeks to reduce cancer incidence,
mortality, and morbidity in its Northern California catchment area, nationally, and globally. The principles of
precision cancer medicine and precision population health systematically and intimately link research and
clinical service delivery for patient and population benefit. The HDFCCC builds on the richness of the basic
biological insights and the extensive and exceptional clinical research and facilities at UCSF, one of the world's
leading health research universities. Moreover, its location in the San Francisco Bay Area allows the HDFCCC
to take advantage of one of the most culturally diverse populations and highly innovative and intellectually
vibrant environments in the world. This is accomplished through the ten Research Programs supported by
seven Shared Resources and clinical and administrative infrastructure.

Public health relevance
Director's Overview: Project Narrative The UCSF Helen Diller Family Comprehensive Cancer Center (HDFCCC) seeks to reduce cancer incidence, mortality, and morbidity in its Northern California catchment area, nationally, and globally. The principles of precision cancer medicine and precision population health systematically and intimately link research and clinical service delivery for patient and population benefit.